Administration

PROJECT SUMMARY/ABSTRACT
Markey Cancer Center (MCC) Administration provides efficient and effective administrative support to
MCC's Director, Senior Leadership, Research Program Leaders, Shared Resource Facility (SRF) Directors
and MCC members. The role of MCC Administration is to operationalize MCC's most critical research functions
by fulfilling the following Specific Aims: 1) to accelerate the remarkable evolution of the MCC by leveraging
resources and expanding MCC's infrastructure; 2) to promote the strategic planning and evaluation efforts of
the MCC; and 3) to support the comprehensive basic science, clinical and cancer prevention activities of the
MCC by fostering transdisciplinary and translational science. The MCC is a matrix cancer center with
administrative staff providing support to 119 MCC members from 28 departments in 8 University of Kentucky
colleges, with 28 faculty recruited in the last 4 years. MCC Administration leverages the expertise of its team
members while operating in an innovative and efficient manner. New initiatives supported since the last grant
cycle include: 1) implementing iLab Solutions (Agilent Technologies) across SRFs; 2) deploying $4.2M for new
seed grant opportunities; 3) developing the “Markey Women Strong” program in collaboration with the Markey
Cancer Foundation to provide two $50,000 awards annually to female researchers in the MCC; 4) supporting a
38% increase of direct cancer-related research funding from $19.9M to $27.4M (corresponding 36% increase
of total cancer-related research funding from $28.4M to $38.7M) between 2012-2017; 5) facilitating 7
successful CCSG supplement applications; 6) initiating development of 2 SRFs (Oncogenomics and Behavior
and Community-Based Research); 7) providing full support for a Center of Biological Research Excellence
application and funded award; 8) establishing the Department of Toxicology and Cancer Biology and the
Center for Environmental and Systems Biochemistry to support research and educational efforts; 9) increasing
the number of MCC Network sites from 8 in 2013 to 24 in 2017; 10) creating the MCC Research Network; 11)
promoting communication throughout the MCC and catchment area with a new website and additional social
media platforms; 12) fostering growth of the Clinical Research Office and creating the Clinical Research
Enrollment and Development of Investigational Trials program to recognize faculty for clinical research efforts;
13) overseeing the expansion of space, including a dedicated Precision Medicine Center (PMC), a new
inpatient floor with 63 additional beds and dedicated administrative space for the MCC Affiliate and Research
networks; 14) planning utilization of 2 MCC research floors (50,329 sq. ft.) in the new Research Building 2,
scheduled to open in 2018; 15) creating the MCC Community Outreach Program and establishing the annual
Expressions of Courage event for cancer survivors; and 16) facilitating development and implementation of the
2017-2022 Strategic Plan.